Normal Aging Lung Cell Atlas (NALCA)

PROJECT SUMMARY
The overall objective of the ‘Normal Aging Lung Cell Atlas’ (NALCA), our response to RFA-HL-19-012
(Deciphering the Molecular Landscape of Lung Aging in Humans UO1), is to generate a compendium of the
dynamic cell specific changes in mRNA, microRNA, and epigenetic marks that happen during lung aging with a
focus on single cells and the alveolar microenvironment. We plan to use this compendium to generate a dynamic
temporal regulatory model of normal human lung aging. The investigators on this application have significant
expertise in lung genomics, epigenomics, bioengineering, aging, alveolar development, systems and
computational biology. The premise of this proposal lies in the availability of resources, including normal human
lungs at different ages, aged wild-type as well as aging relevant genetically modified mice, unique expertise in
high throughput technologies including single cell RNAseq, laser capture microdissection, methylation profiling,
proteomics and tissue engineering, and proven track record in developmental of analytical approaches that
dissect temporal regulatory networks. It is also largely benefitting from synergisms with other non-overlapping
NIH-NHLBI and NIH-NIA projects headed by the coinvestigators on this proposal. We will address the objectives
of this project by the following specific aims: Specific Aim 1. To identify cell and microenvironment specific
changes in coding and non-coding RNAs across human lung aging. We will perform single cell RNAseq of all
the cells in the human lung across the spectrum of normal aging utilizing a unique collection of aging lungs.
Analysis of lung microenvironments by LCM RNAseq will be performed in parallel on the same lungs, analyzing
changes in alveoli, capillaries and inflammatory infiltrates. Aging methylation markers and cell specific validations
will also be performed. Specific Aim 2. To identify key time points in lung aging using detailed temporal analysis
of mouse lung aging. We will perform single cell RNAseq of lungs of wild-type mice of both sexes at multiple
time points to identify the exact time points in which key changes in gene expression occur. We will then analyze
these time points in detail, utilizing genetically modified mice with altered lifespan and aging mechanisms.
Proteomic analysis will be performed on overlapping mouse and human key time points. Specific Aim 3. To
develop a comprehensive transcriptional dynamic regulatory multicellular model of lung aging. We will use and
extend our analytical tools to model specific dynamic signaling, regulatory networks, and cellular interactions, at
the single cell level in lung aging. The model will provide insights and will be shared with the scientific community,
through a highly interactive and intuitive web interface called Aging Lung Dynamic Regulatory Multicellular Model
(AgeDREMM) that will allow visualization and sharing of our results.

Public health relevance
PROJECT NARRATIVE The molecules and regulatory processes involved in lung aging are highly complex and we do not have a comprehensive understanding of this process. The overall objective of the Normal Aging Lung Cell Atlas project is to identify cell and microenvironment specific molecular regulatory events that happen during normative lung aging and use them to develop novel biomarkers and therapeutics. We will share those with the scientific community, through a highly interactive and intuitive web interface called AgeDREMM: the aging lung dynamic regulatory multicellular model.